Aging, Macrophage Mediators, and Burn Trauma

Project Summary
The proposed studies will examine mechanisms by which morbidity and mortality are greater in older burn
patients. Regardless of age, most burn patients do not die from primary injuries but rather from complications,
such as pneumonia and multiple organ failure (MOF). Clinical and experimental evidence reveal that healthy
aged subjects are in an elevated basal inflammatory state, referred to as “inflamm-aging,” which can slow the
immune system's response to invading pathogens. We and others believe that inflamm-aging is caused by
translocation of bacterial products from the intestinal lumen and that continuous exposure to these products
triggers the production of pro-inflammatory cytokines, including interleukin (IL)-1β and IL-6. In addition, shifts in
the intestinal microbiota in the aged can promote systemic inflammation and these shifts are much more
dramatic after burns. Novel preliminary data in our clinically-relevant mouse model of burn injury confirm that
aged burn-injured mice have heightened circulating levels of danger-associated molecular patterns (DAMPs), a
greater breach in intestinal epithelial barrier integrity, and more dramatic dysbiosis of the fecal microbiome
relative to their young counterparts. Moreover, we know from our recent work on burn patients that advanced
age upregulates pro-inflammatory mediators in the lungs and blood, which parallels our mouse studies. From
these observations, we hypothesize that, relative to young, older subjects who sustain a burn injury have
greater 1) breach in the integrity of the intestinal epithelial barrier and 2) shift in the intestinal microbiome,
leading to excessive systemic inflammation and damage to critical organs, like the lung. To test the concept of
the post-burn “gut-lung axis,” in Aim 1, we will examine intestinal barrier integrity in burn-injured young and
aged mice over time using blood-borne and fecal biomarkers of intestinal damage and determine if restoring
the intestinal barrier reduces inflammation and improves function of distant organs, including the lung. In Aim
2, we will examine levels of a subset of gut and lung antimicrobial peptides (AMPs), determine the extent of
fecal microbiome dysbiosis, and investigate whether modulating AMP levels restores normal intestinal and
pulmonary parameters in young and aged burned mice. Lastly, in Aim 3, we will study burn patients
longitudinally to determine if the superimposed impact of burn injury with advanced age alters intestinal barrier
integrity and fecal microbiota to a greater extent than seen in younger subjects with equivalent size burns.
Moreover, we will see if there is a relationship between intestinal dysregulation and systemic/pulmonary
inflammation by assessing blood-borne and fecal biomarkers of intestinal damage and microbial dysbiosis and
determine if these biomarkers can be used to predict acute hypoxic respiratory failure and poor immune
response following pulmonary infections. These studies will expand our understanding of how advanced age
alters the gut in the context of burn injury and its systemic implications. Our work may also lead to the
development of novel therapies for the treatment of patients with burns and other forms of trauma.

Public health relevance
Project Narrative Damaging more than just the skin, burn injuries can lead to sepsis and multi-organ failure, often stemming from a breach in the intestinal epithelial barrier allowing translocation of bacteria and bacterial products into systemic circulation, triggering excessive inflammation in critical organs like the lung. Advanced age is an independent risk factor for mortality after burn injury, even in patients with relatively small burns, in part, because elderly burn patients are unable to combat infectious challenges, like pneumonia, a common complication seen after traumatic injury. By identifying mechanisms responsible for early damage to the gut barrier after injury and tracking dysbiosis and eventual restoration of the fecal microbiome in both our murine model of burn injury and in older burn patients, we hope to reduce the impact of this post-burn pathophysiology in patients who are at risk of developing lung infections and respiratory failure